Functions of the largest HSV-1 virion protein, pUL36

Herpesviruses are major human pathogens that cause life-long persistent infections and result in clinical
manifestations that range from a mild cold sore to cancer. Herpes simplex virus (HSV) is among the most
frequently encountered pathogen by the general population. Infection with HSV-1 often results in oralabial
disease but it can also cause ocular disease (keratitis) that can lead to blindness or encephalitis, which can be
fatal. Type-2 infections are characterized by genital ulcerative disease and infections of the newborn. There is a
concerted effort to develop new compounds that block the replication of the virus or a vaccine that can prevent
disease. Drugs are being developed that not only target the DNA replication enzymes but also other aspects of
the virus life cycle that are amenable to inhibition. The herpesvirus virion is comprised of four structural
components: an icosahedral capsid, which encloses the viral DNA genome; an electron dense asymmetrically
distributed material, which immediately surrounds the capsid and is termed the tegument; and an outer
membrane or envelope, which encloses the tegument and capsid and in which are embedded the viral
glycoproteins. Maturation of the capsid into an infectious particle is an essential process and thus potentially a
step that can be blocked using a drug or inhibitor. The UL36 gene product is the focus of this proposal. The
pUL36 protein, which is resident in the inner-tegument is essential for virus maturation, in its absence, capsids
are packaged with genomic DNA and even exit the nucleus (primary envelopment) but subsequently fail to
undergo secondary envelopment. This large protein of 336 kDa encodes multiple functions and activities and
the protein domains of many of these functions have been mapped and examined in detail. The premise and
impetus for undertaking this study, is the observation in preliminary experiments of mutations in UL36 that allow
virion morphogenesis. These completely enveloped particles are non-infectious. We will rely on our strength and
experience in molecular genetics and cell biological approaches to begin to delineate the impact of these types
of mutations on pUL36 activities.
Hence, the goal of this proposal is to delineate sites of this protein that could shed light on how pUL36
functions beyond cytoplasmic envelopment. This project is limited to completion of these studies for an
important viral protein and satisfies the criteria of an R03 small grant format.
The Specific Aims proposed to achieve these goals are:
Specific Aim 1: Discover mutant sites in pUL36 that result in the formation non-infectious enveloped virus.
Specific Aim 2: Discover how pUL36 functions post-morphogenesis.

Public health relevance
Narrative: In this application we propose to discover how the largest herpes simplex virus type-1 (HSV-1) tegument protein encoded by UL36 functions in activities post-cytoplasmic morphogenesis. By taking advantage of our strength in genetics and cell biological approaches to study HSV-1 genes and their products we hope to begin to uncover how this protein functions at the earliest stage of infecting a cell.